Wisconsin Nathan Shock Center

Abstract Overall
The goal of the Wisconsin Nathan Shock Center (WiNSC) is to catalyze research at the interface of aging,
metabolism, and translation, building an environment and infrastructure that will have a significant impact locally
and nationally. A solid body of literature supports the concept that the pace of aging is malleable and that loss
of health in advanced years is not an inevitability. A striking commonality among the set of aging-regulating
factors identified to date is their connection to metabolism. The importance of metabolic integrity extends beyond
the fundamental biology of aging to the biology of disease, and the most common age-associated diseases and
conditions including cancer, cardiovascular disease, diabetes, and neurodegenerative disease, all feature
metabolic dysfunction. The regulation of metabolism itself is highly complex, but as a discipline, metabolism
research offers the advantage of manifesting across timeframes, from acute to chronic, and across scales, from
cells to tissues to whole organisms. As such, our theme will have broad appeal and will make a significant impact.
To accomplish its goals, WiNSC will conduct a host of research and training activities, creating an
environment that facilitates cutting-edge research in the general field of aging biology with a specific focus on
the intersection of aging, metabolism, and translation. The ability of WiNSC to achieve its mission is supported
by a strong institutional environment and commitment, as well as a leadership team comprised of nationally- and
internationally-recognized experts in the specific areas of focus. Our strategic goals are a) to promote,
coordinate, and enhance research in the basic biology of aging with a specific emphasis on aging, metabolism,
and translation, which will be achieved through the coordinated action of the Administrative Core and the
Research Development Core; and b) to efficiently and rapidly advance cutting-edge research at the intersection
of aging, metabolism, and translation by developing novel research capabilities and leveraging existing
resources, which will be accomplished through the establishment of three Research Cores, the Energetics of
Longevity Core, the Discovery and Integration Core, and the Translation and Application Core. The WiNSC is
designed to advance research on aging, to devise and test novel hypotheses at the intersection of aging and
metabolism, and to promote and advance translation of insights from basic biology of aging studies. Our
interdisciplinary team has expertise in the requisite areas of research, our focus on metabolism naturally allows
for integration of cellular and tissue level research with systems level endocrinology and physiology, and our
centralized infrastructure facilitates the development of emerging areas of investigation and fosters collaborative
programs to advance the field, drawing upon deep local expertise and extending capabilities to the wider aging
research community. Through its unique focus on metabolism and translation the WiNSC is exceptionally well
positioned to advance biology of aging research and contribute significantly to the NSC Network.

Public health relevance
Narrative Overall The goal of the Wisconsin Nathan Shock Center (WiNSC) is to promote, coordinate, and enhance research in the basic biology of aging with a specific emphasis on metabolism and translation, and to efficiently and rapidly advance cutting-edge research nationally by developing novel research capabilities and leveraging existing outstanding resources at the University of Wisconsin-Madison. The WiNSC is exceptionally well positioned to advance biology of aging research in this thematic area and will contribute significantly to the NSC Network.